Deciphering Male- and Female-coordinated Gating Mechanisms that Ensure Plant Reproductive Success

Project Summary
Reproduction in flowering plants depends on multiple male (pollen)-female (pistil) interactive steps to
deliver sperm, which are non-motile and transported as cytoplasmic cargos by the pollen tube through
several specialized pistil tissues to the female target for fertilization, leading to seed production. The
proposed research addresses key cell-cell communicative events in three distinct prezygotic (i.e. prior to
sperm-egg fusion) phases during the pollen/pollen tube journey in the pistil to enable fertilization. Long-
term efforts in our lab have set discovery milestones for the field and recently elucidated key molecular
players in each of these phases, providing critical advances and unprecedented opportunities for the
mechanistic dissection proposed here. The pistil supports pollen germination on its receptive surface, the
stigma, to produce a pollen tube that grows inside the transmitting tissue to reach the target egg-bearing
chamber, the female gametophyte located inside an ovule. Once arriving at the female gametophyte, the
pollen tube burst, releasing sperm for fertilization, producing seed. The pistil also set up barriers to ward
off unwanted mates or invasive disease agents, and to effectively prevent multiple pollen tubes from
penetrating the same female gametophyte to suppress polyspermy and ensure progeny health. We
discovered three related signaling modules, each critical for one the three prezygotic phases. Phase 1
supports pollen germination on the stigma. Phase 2 achieves two goals, one ensuring pollen tube integrity
until it reaches its target, the other ensuring single pollen tube entry into an ovule. Phase 3 occurs at the
pollen tube/ovule and pollen tube/female gametophyte interfaces. Interactions here induce bursting of
the first-arriving pollen tube in the female gametophyte and trigger a mechanism for a local polyspermy
block to further ensure against supernumerary pollen tube entry into an already penetrated female
gametophyte. These signaling modules are anchored by the pistil-expressed receptor kinase FERONIA
or pollen-expressed homologs, each partnering with a GPI-anchored protein (GPI-AP) LORELEI (LRE)
or LRE-like GPI-AP1,2,3 (LLG1,2,3) to serve as coreceptors for peptide ligands called RALFs (Rapid
Alkalinization Factors). Here we propose experiments to elucidate how these signaling modules and
additional regulatory factors impact the molecular interactions, biochemical processes and cellular
conditions in pistillate cells to mediate success for these prezygotic phases, enabling fertilization, and to
prevent unwanted intrusions. Plants have evolved but hidden in the most protected location these highly
sophisticated cell-cell communication strategies to ensure their own proliferation. Our expertise positions
us uniquely capable of achieving these goals, which will fill a complete mechanistic void, setting
paradigms to guide studies in many ecologically and agriculturally important plants, and inform rational
designs to safe-guard reproductive success, ensuring food security to provide for global nutritional needs.

Public health relevance
Public Health Relevance/Narrative Reproduction in flowering plants produces seeds thus provides for global nutritional needs, food security, and ensures ecological balance that is important for climate health. Yet the process involves complex male-female interplays and is highly sensitive to the environment, such as high and low temperatures, drought and flood, and reproductive failure devastates seed yields. Understanding the molecular mechanisms that lead to plant reproductive success will help designs of counter measures to reproductive loss and therefore relevant to NIH commitment to fundamental research in model organisms whose success ultimately protects human health.